Center for Pediatric Brain Health

Abstract/Summary: Administrative Supplement for the Center for Pediatric Brain Health
The Center for Pediatric Brain Health is a NIGMS COBRE at Boys Town National Research Hospital (BTNRH)
that recently entered its second year. The Center is housed in the new, state-of-the-art, 15,000+ square foot
Institute for Human Neuroscience building on the main Boys Town campus. The key components of the Center
include the Administrative Core, one research core (i.e., the Neural Quantification and Imaging Core), four
research project leaders (RPLs), a Supervisory and Mentoring Committee, and a cohort of established pediatric
neuroscientists. The Center has unique strengths in the area of dynamic neuroimaging, with one of the largest
and most productive magnetoencephalography (MEG) groups in the world. MEG is a noninvasive neuroimaging
method with millimeter spatial precision and millisecond temporal resolution that is ideal for studying children
due to its open, non-claustrophobic design and completely silent data acquisition environment. However, like
MRI and other human neuroimaging modalities, the method is susceptible to participant movement, which has
typically limited its application to children who are typically about six years or older.
In 2022, the Center for Pediatric Brain Health installed the first high-density optically-pumped magnetometry
(OPM) unit in North America. OPM is a new method that measures the same magnetic fields detected in MEG
but does so by harnessing recent breakthroughs in quantum physics that were rapidly accelerated by President
Obama’s BRAIN Initiative. These key breakthroughs allow the sensors to operate at room temperature and be
placed directly on the scalp, which means the measured magnetic fields are much stronger than in MEG (i.e.,
improved signal-to-noise ratio) and the sensors move with the head. The latter quality means that OPM is much
more tolerant of head motion than MEG, MRI, and other comparable imaging modalities and thus enables high
resolution imaging in very young children. Our current OPM array contains 128-channels and is optimized for
older adolescents and adults and has been used extensively despite the short time since installation. During
this time, we have also made custom arrays for babies as young as three-months-old by attaching the OPM
sensors to baby hats (e.g., beanie caps) using custom 3D-printed clips. While such innovation has helped
move us forward, a dedicated array for neonates, infants, and other very young children would revolutionize
this work and lead to high precision dynamic functional maps of neural activity from babies at the earliest
stages of life. Further, such a second array would allow “hyper-scanning” of parent-child dyads and illuminate
how some of the most important social interactions in life shape the trajectory of brain development thereafter.
Thus, through this administrative supplement and significant institutional funding, we are requesting support to
acquire, install, and integrate a 64-channel OPM array for advancing pediatric neuroscience. When complete,
this OPM system will be the first of its kind in the world and advance multiple research programs associated
with our Center, while also establishing the Center as an international hub for developmental neuroscience.

Public health relevance
Project Narrative: Administrative Supplement for the Center for Pediatric Brain Health The Center for Pediatric Brain Health is a NIGMS-supported Center of Biomedical Research Excellence (COBRE) located at Boys Town National Research Hospital that specializes in pediatric neuroimaging, brain health, and developmental neuroscience, with key strengths in brain dynamics, neurophysiology, and network- level communication. Through the proposed administrative supplement and significant institutional support, a new optically-pumped magnetometry (OPM) array will be added to the Center’s Imaging Core, which will enable high-precision, dynamic functional imaging of neonates and very young children, as well as simultaneous imaging of brain function in parent-baby dyads. This will be the first such system in the world and help advance the research programs of multiple Center-associated investigators, while also helping to establish the Center as an international hub for dynamic pediatric neuroimaging.